LIMBER UniLeg: A digital and additive manufacturing approach for accessible prosthetic care.

Summary
The technology LIMBER aims to provide is an all-inclusive service that enables the rapid and scaled-up manufacturing of
customized prosthetics on-demand for amputees. The World Health Organization (WHO) estimates that out of the tens of
millions of amputees worldwide, only 5% to 15% have access to prosthetics or other assistive devices. The lack of
widespread availability is because most rehabilitation devices are designed and hand-crafted by prosthetists through a
complex and time-consuming process.
This Phase I SBIR proposal will confirm the feasibility of LIMBER’s prosthetic design and manufacturing system that
overcomes the custom-care and cost barriers by combining the latest in 3D scanning, digital design, and additive
manufacturing technologies to increase the capacity of professional prosthetists and provide access to affordable and
functional ‘unibody’ transtibial prosthetic limbs that are comfortable, lightweight, and automatically fabricated.
LIMBER’s process leverages the structured light scanning capability embedded in smartphones to create a digital twin of
an amputee from the waist down. Scanning can be accomplished in minutes by a prosthetist or trained technician, further
improving efficiency and alleviating bottlenecks of the conventional process. The data is then transferred to LIMBER’s
cloud, where our skilled prosthetists transform it into a personalized single-piece (socket, pylon, and ankle-foot combined)
prosthetic device that is 3D printed. After working with 15 lower-limb amputees, our preliminary findings include a
reduction in the average cost, weight, and time of production by 79%, 55%, and 66%, respectively.

Public health relevance
Narrative LIMBER’s mission is to provide worldwide accessible prosthetic care, with the vision of getting every amputee back on their feet with dignity. With this Phase 1 SBIR, LIMBER Prosthetics & Orthotics, Inc. proposes to confirm the feasibility of a new prosthetic design and manufacturing system that overcomes the custom-care and cost barriers facing amputees by combining the latest in 3D scanning, digital design, and additive manufacturing technologies to increase the capacity of professional prosthetists and provide access to affordable and functional ‘unibody’ transtibial prosthetic limbs that are comfortable, lightweight, and automatically fabricated.